The academic-community experience (ACE): A postdoctoral training fellowship in implementation science to promote mental health

1 The University of Pennsylvania Training Program in Implementation Science and Mental Health is the only NIMH-
2 funded T32 program in the United States that provides training exclusively in implementation science and mental
3 health. This renewal application requests 5 years of funding to continue to train the next generation of scientists
4 who will study how to improve implementation of assessment, prevention, and intervention practices that can
5 transform mental health delivery across the lifespan. Since 2016, we have prepared 9 postdoctoral fellows, 44%
6 of whom met NIH criteria for underrepresented populations; 89% of whom were female. Those who have
7 graduated have faculty positions across the country. We will continue to provide training to postdoctoral fellows
8 per year and request additional slots for predoctoral trainees. Over the past 35 years, faculty in Penn's Center
9 for Mental Health have collaborated closely with community agencies, including Philadelphia County's
10 behavioral health Medicaid agency, the Philadelphia Departments of Health and Behavioral Health, the School
11 District of Philadelphia, the justice system, the Department of Veteran Affairs, and Penn Medicine. Through these
12 partnerships, we create unique opportunities to embed postdoctoral trainees in the settings in which they hope
13 to conduct implementation research. Penn has emerged as a leader in implementation science, with numerous
14 resources including the Penn Implementation Science Center, founded and directed by Contact PI Beidas, and
15 foundational and advanced coursework in implementation science. The proposed training program includes
16 seven experienced investigators from Penn and two community partners as part of the core executive committee.
17 Additional mentors are available from other schools at Penn including the Wharton School of Business and
18 investigators from other local institutions (Drexel, Temple)to encourage interdisciplinary inquiry and cutting-edge
19 knowledge. Further, a group of national leaders in implementation science (Senior Scholars) interact with
20 trainees regularly. We propose the following aims for our T32: Our trainees will (1) Participate
21 based
22 implementation
23 additional
24 science
25 from c
26 consultant.
27 partner Our T32 brings together trainees and mentors creating a fertile
28 interdisciplinary environment in which to train the next generation of implementation scientists. Successful
29 trainees are future leaders in reducing the research-to-practice gap and scaling up the use of evidence-based
30 practices in community settings.
in didactic training,
on a personalized needs assessment. Both pre and postdoctoral trainees will take two core courses in
(foundational and advanced implementation science); predoctoral trainees will take any
courses r equired by their doctoral programs; (2) Receive mentorship from a core implementation
and mental health faculty member, an additional content mentor if applicable, and a community partner
a state, city, or ommunity organization; and (3) Partner with a practice site to serve as an implementation
Trainees will develop and conduct a small implementation research project with their community
that will lead to an F, K, or R grant.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
PROJECT NARRATIVE The University of Pennsylvania Training Program in Implementation Science and Mental Health is the only NIMH- funded T32 program in the United States that provides training exclusively in implementation science and mental health. Our trainees have developed successful careers applying methods from implementation science to improve mental health services in schools, specialty mental health, primary care, and juvenile justice. We will continue to provide training to postdoctoral trainees and request additional slots for predoctoral trainees. Successful trainees will continue to be leaders in advancing our understanding of the best ways to improve mental health through broad-scale implementation of EBPs in a variety of settings, in line with the fourth objective of the National Institute of Mental Health's (NIMH) strategic plan. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page